Task 2: The Biopharmaceutical Product Development Services Program

This contract provides for process development and related development and cGMP manufacture and related activities of biopharmaceutical products under the NIAID Preclinical Services for the Development of Biopharmaceutical Products Program.